Deciphering the roles of RIFIN and STEVOR parasite antigens in severe malaria pathogenesis via transcriptomics and immune profiling

PROJECT SUMMARY
Despite decades of research, Plasmodium falciparum malaria continues to kill hundreds of thousands of children
in sub-Saharan Africa each year. Vulnerability to severe malaria is complex, involving both host and parasite
factors. Blood type A is an established risk factor for severe malaria, whereas blood type O is associated with
protection from complicated symptoms. The exact mechanism of this phenomenon is incompletely understood
but may involve interactions mediated by particular parasite antigens. RIFINs and STEVORs are highly diverse
parasite protein families that are displayed on the surface of infected red blood cells. Recent laboratory studies
suggest that these antigens may exacerbate malaria severity through multiple mechanisms, including adherence
to nearby red blood cells to form “rosettes” that envelop the parasite and protect it from immune clearance.
Certain RIFINs bind preferentially to type A red blood cells. STEVORs have a similar binding preference for
glycophorin C, another red blood cell surface protein. These intriguing findings suggest that RIFINs and
STEVORs may be central to P. falciparum virulence and drive differences in susceptibility to severe disease
between blood types. Despite promising in vitro links to severe malaria vulnerability, the immense
diversity of the RIFIN and STEVOR families has so far precluded the comprehensive study of these
antigens in clinical infections. The goal of this proposal is to identify RIFIN and STEVOR subtypes that are
associated with severe malaria in African children. We will obtain blood and serum samples from children with
severe or non-severe malaria in Mali, Malawi, and Uganda, representing three regions of sub-Saharan Africa
with distinct malaria transmission patterns. In Aim 1, we will identify the expressed rif and stevor transcripts in
individual blood samples using reference-free RNA-Seq, then compare the abundance of transcript subgroups
between severe and non-severe malaria. In Aim 2, we will profile antibody responses against a comprehensive
microarray of RIFIN and STEVOR variants to identify immune “gaps” in children with severe malaria compared
to non-severe malaria. RIFIN and STEVOR antigen subtypes that were preferentially expressed and/or not
serorecognized in severe malaria infections may be important mediators of pathogenesis. RIFINs that
predominate in severe cases with blood type A may be critical aspects of this group’s vulnerability. The proposed
aims will help clarify the role of RIFINs and STEVORs in severe malaria pathogenesis and inform the
development of tailored vaccines and therapeutics to protect the most at-risk children in sub-Saharan Africa. The
applicant will develop and apply hands-on skills in transcriptomics, immunoepidemiology, and international
clinical research design and management, critical to his intended career as a 21st century molecular
epidemiologist.

Public health relevance
PROJECT NARRATIVE Malaria kills hundreds of thousands of children in sub-Saharan Africa each year, but it remains unclear why some infections progress from mild to severe illness. Laboratory studies suggest that diverse parasite antigens called RIFINs and STEVORs may have several roles in severe malaria pathogenesis, but they have not been studied in clinical infections. The goal of this proposal is to identify RIFIN and STEVOR subtypes that are associated with vulnerability to severe malaria in sub-Saharan African children, illuminating the importance of these proteins in pathogenesis and informing the development of vaccines and therapeutics.